Racial/Ethnic Disparities in Health Care and Challenges in Insurance Plan Choices among Older People with Alzheimer’s Disease and Related Dementia: A Mixed Methods Study of Medicare Options

Project Summary/Abstract
Medicare is the primary health insurance for older adults (65+) living in the U.S. Eligible beneficiaries must
choose between two different plan types: traditional Medicare (TM) and Medicare Advantage (MA). MA
enrollment has doubled in the last decade, currently covering about 45% of all Medicare beneficiaries. This
growth has been driven, in part, by an increasing proportion of Black and Hispanic MA enrollees. While
evidence suggests that some MA patient populations receive better-quality care and experience fewer
racial/ethnic health disparities, it is unknown whether this is true for socioeconomically disadvantaged Black
and Hispanic Medicare beneficiaries, who are at substantially greater risk of incident Alzheimer’s disease and
related dementia (ADRD). Because they have more complex healthcare needs but receive less coordinated
care and fewer preventive services, they are at significantly higher risk of potentially preventable
hospitalization, 30-day hospital readmission, and other adverse health events than their White counterparts.
Further, there is considerable variation in the quality of MA plans. Many MA plans in Black- and Hispanic-
populated counties have low quality ratings, which may contribute to racial/ethnic health disparities. Moreover,
beneficiaries’ health plan decision-making is complex, potentially exacerbating racial/ethnic health disparities
among ADRD beneficiaries. Finally, racial/ethnic health care disparity research has been mainly observational
and descriptive, thus limiting its usefulness in informing policy. The specific aims of this mixed methods study
are to use innovative econometric causal methods to (1) examine and explain racial/ethnic disparities in 16
measures of care continuity, receipt of preventive services, and quality of care in MA vs. TM; (2)
examine racial/ethnic disparities within and between MA plans in 16 measures of care continuity,
receipt of preventive services, and quality of care; and (3) explore health plan decision-making
challenges among beneficiaries with ADRD and/or their caregivers. Our multidisciplinary team, with
decades of experience in ADRD research, racial/ethnic healthcare disparity analysis, claims data and
econometrics, qualitative and mixed methods, and health policy is uniquely qualified to conduct this innovative
research. This study will inform Medicare policies to promote more equitable health care and facilitate easier
health plan decision-making for socioeconomically disadvantaged Black and Hispanic Medicare beneficiaries
with ADRD. With our national Policy Advisory Committee of stakeholders, including a beneficiary with ADRD
and/or a caregiver, we are well-positioned to disseminate findings and promote quality and equitable health
care for racial/ethnic minority Medicare beneficiaries with ADRD.

Public health relevance
Project Narrative Medicare is the primary health insurance for older adults (65+) living in the U.S., and eligible beneficiaries must choose between two different plan types: traditional Medicare and Medicare Advantage. The number of socioeconomically disadvantaged Black and Hispanic Medicare beneficiaries with Alzheimer’s disease and related dementia (ADRD) is growing, and they experience less preventive care and more adverse health events than their White counterparts. The proposed mixed methods study will examine racial/ethnic health disparities within and between the two Medicare plan options and explore the challenges of health plan decision-making among beneficiaries with ADRD to inform policies promoting more equitable health care and facilitating better health plan decision-making for socioeconomically disadvantaged Black and Hispanic Medicare beneficiaries with ADRD.